Dissemination

Project Description Through Dissemination Core activities, the Washington University (WU) Biomedical Mass Spectrometry (MS) Resource achieves the fundamental goal of sharing, distributing, providing access and technical support for MS technology and software with the broad research community. The Dissemination Core will accomplish this goal by sharing, distributing, and hosting many broad outreach programs focused on MS and related technologies developed in the Resource, including: an informative website with tutorials and distance learning modules; peer-reviewed publications, reviews, books and special editions of technical journals; press releases; conference, symposia, seminar, and workshop presentations; software; and instruments, technology, and methods shared directly with other laboratories and industry.

Public health relevance
Project Narrative-Public Health Relevance. The Washington University Biomedical Mass Spectrometry Resource has a longstanding history as an active and productive citizen in the NIH Biotechnology Research Resources community. We propose to extend our mission by advancing mass spectrometry technology, development, and research, applying these discoveries to answer critical biomedical research questions, and training the next generation of researchers, towards the ultimate goal of improving public health.